Lifespan Vascular Biology on White Matter

Project Summary / Abstract
Vascular biology and white matter may be some of the key junctures that harbor early risk mechanisms that
precipitate vascular contributions to cognitive impairment and Alzheimer's disease. This process may start as
early as adolescence and young adulthood, and through our lifespan. While cardiovascular impacts on white
matter health are well-established, our understanding of the lifetime course and the associated mechanisms
are less clear. Our efforts aim to identify the earliest possible vascular biomarkers and risk factors for abnormal
white matter changes for the corresponding cognitive declines. Cardiovascular-brain studies typical focus on
structural imaging changes that are difficult to reverse. We hypothesize that white matter lifespan changes can
be more sensitively tracked by combining standard structural imaging techniques with state-of-the-art
connectome era multimodal imaging. The goal is to uncover novel vascular - white matter mechanisms and
biomarkers that provide early warnings before the irreversible structural changes occur. The proposal builds
upon the productivity of the Amish Connectome Project as baseline data, and leverages the collaboration
between our brain imaging and cardiovascular medicine groups. The Old Order Amish/Mennonite population
has a more uniform genetic profile, rural lifestyle and low alcohol and tobacco use that greatly reduce
uncontrollable variability, thus providing a particularly advantageous platform to study the vascular
mechanisms on white matter. Cerebral white matter will also be studied in the context of predicting white
matter vulnerability to Alzheimer's disease. Tracking when the aberrant vascular – white matter coupling
occurs may provide insights into the timing and mode for more effective prevention. This proposal is
responsive to the new NIH Inclusion Across the Lifespan policy. If successful, the proposed study should
strongly support the prevention goal highlighted in the National Alzheimer's Project Act, which supports
increased public research to prevent the onset of and develop effective treatments for AD by 2025. Prevention
programs can be benefited by more nuanced understanding of the pathways connecting early vascular
changes to irreversible white matter changes. Therefore, we propose to use cutting-edge white matter imaging
that is informative of the underlying mechanisms, combined with standard but state-of-the-art vascular
assessments, to study the interaction between vascular and white matter changes across lifespan.

Public health relevance
Project Narrative Age-related cognitive decline and dementia put an increasingly heavy burden on patients, families, and communities, and may be slowed or in many cases preventable if the key mechanisms can be identified. One of such mechanisms can be the life-time arterial vascular impacts on cerebral white matter, the portion of the brain connecting different brain regions. This study will track the lifespan relationships between several vascular functional mechanisms and white matter lifespan changes, to identify the key mechanisms that may aid prevention efforts against vascular contributions to cognitive impairment and Alzheimer's disease and promote normal, successful aging.